Effects of early Retinoic Acid signaling on valve development

Project Summary/Abstract
Congenital valve defects (CVDs) constitute some of the most common human congenital heart defects (CHDs).
CVDs that lead to valve disease later in life, which can result in heart failure, stroke, blood clots, and even sudden
cardiac arrest. The most common therapy for valve diseases is invasive valve replacement surgery, which is one
of the most common procedures in the cardiac surgery market at nearly 182,000 per year in the USA, making
up nearly a quarter of the total procedural volume. Therefore, elucidating the early developmental and patterning
mechanisms driving normal cardiac valve development will give us novel insight into the etiology of CVDs.
Retinoic acid (RA) is the most active metabolic product of Vitamin A (retinol) within vertebrate embryos and is
reiteratively required for normal vertebrate heart development. Perturbations of RA signaling have been
associated with multiple types of CHDs, including CVDs, as well as valve diseases at later stages of
development. However, embryos devoid of early RA exhibit enlarged hearts due to the increased specification
and differentiation of cardiomyocytes. Despite the known requirements in heart development and previous
studies implying RA signaling is required for cardiac valve formation and maintenance, we still do not have clear
understanding of the requirements of early RA signaling in vertebrate valve development. Our preliminary work
using zebrafish shows that early inhibition of RA signaling results in an enlarged atrioventricular canal (AVC),
characterized by an expansion of myocardial AVC markers, which is consistent with the enlarged hearts in RA
deficient embryos. Surprisingly, despite the enlargement of the myocardial AVC region in RA deficient embryos
and expectation that this would result in typically larger valves, we find that the overlying atrioventricular valves
(AVVs) do not form, suggesting that a factor signaling from the myocardium to the overlying endocardium
necessary to promote AVV induction is lost. Our preliminary data show that canonical Wnt signaling is lost within
AVC cardiomyocytes following early inhibition of RA, suggesting that we have identified a new signaling node
necessary to promote normal AVV development. In Aim 1, we will test the hypothesis that early RA signaling
directly establishes cardiac progenitors sufficient to turn on Wnt signaling later in the AVC myocardium required
for AVV development. In Aim 2, we will test the hypothesis that Wnt signaling functions downstream of early RA
signaling in the induction of AVVs. Ultimately, the proposed studies could be used to identify and develop new
therapeutic approaches for treatment to prevent or ameliorate CVDs and their resulting valve diseases.

Public health relevance
Project Narrative Among structural congenital heart defects (CHDs), abnormal valve development makes up the most common malformations, including defects in valve leaflet anatomy and function. While perturbations of retinoic acid (RA) signaling are associated with CHDs, little is known about the role of RA in vertebrate valve development. The results of this proposal will illuminate mechanisms underlying the requirements of RA in vertebrate valve development, which may provide insight into the causes of valve defects and may aid in the generation of novel strategies for the prevention, repair, and maintenance of valve diseases.